Sickle Africa Data Coordinating Center

Project Summary/Abstract (30 lines)
An estimated 305,800 babies are born worldwide each year with Sickle Cell Disease (SCD), with nearly
75% of births in sub-Saharan Africa (SSA). Despite this high incidence, there are currently no effective
public health programs in SSA countries focused on SCD. As a consequence, up to 90% of infants with
SCD in SSA are believed to die needlessly by five years of age. Evidence from high income countries
indicates that interventions such as newborn screening and penicillin prophylaxis can reduce
preventable deaths due to SCD in SSA. Such programs are credited with an ~70% reduction in mortality
rate among children with SCD in the USA. However, the death rate in adult SCD patients in the USA
has not improved in the last thirty years, due to multi-organ complications. There is thus a major need
for research to develop effective therapies across the life span for SCD in all parts of the world. High
regional disease prevalence in SSA would be expected to facilitate research studies on SCD. In 2017,
we established the Sickle Africa Data Coordinating Center (SADaCC) to support the activities of the
Sickle Pan African Research Consortium (SPARCo) sites in Tanzania, Nigeria, and Ghana.
This U24 application seeks to continue SADaCC activities to sustain, enhance, and grow the SCD
Network in Africa, in order to advance SCD-related epidemiological, translational, and clinical
research. This overall objective will be accomplished by five specific aims: Aim 1: To provide overall
coordination and administrative support to the SCD SSA Network, that will include: the facilitation
of interactions and functions, and further development of SOPS and websites; Aim 2: To ensure
maintenance and expansion of the centralized electronic sickle hemoglobinopathy database that
will include: updating data capture forms and registry SOPs; a secure and scalable system for data
collection Aim 3: To provide data management support including: and developing the public-use
quality controlled data sets; a repository management system for biospecimens; the enforcement of
country-specific human subject research regulations. Aim 4: To provide expertise and support for
implementation of research studies, including: planning, design, execution, analysis, reporting,
publication, and dissemination of research studies. Aim 5: To provide effective consortium-wide
participatory milestones and metrics for the SCD Research Network performance and impact. The
SADaCC team’s successful experience as the coordinating center for SickleInAfrica augurs its provision
of sustainable support to an expanded SCD Research Network.

Public health relevance
Project Narrative (3 sentences) Sickle Cell Disease (SCD) is a growing global public health issue, necessitating the need for increased research to develop effective therapies towards improving quality of life and care for SCD patients, through scientifically rigorous methods such as cohort studies, which improve our understanding of risk factors, health and disease outcomes. High disease prevalence of SCD in sub-Saharan Africa (SSA) should facilitate epidemiologic, translational, and clinical research studies on well-coordinated longitudinal cohorts, similar to the Framingham Study for heart disease, and this U24 application is seeking to renew the Sickle Africa Data Coordinating Center (SADaCC) grant to support such studies through activities of the SCD SSA Network. We believe that our prior successful experience in implementing SADaCC activities over the past 3 years; the outstanding institutional environment at the University of Cape Town; and our team’s track record and expertise in complementary basic, translational & clinical research and training focused on SCD in SSA; has the potential to strengthen the effectiveness of SADaCC to support the SCD SSA Network and drive SCD research for better health outcomes.